Core B: Program Development

PROJECT SUMMARY:
Core B
The Program Development Core (B) is intended to support emerging and high-risk innovative
research in rapidly developing areas of aging research. Core B proposes four mechanisms to
achieve this objective: a peer-reviewed pilot grant program to allow faculty to pursue new
concepts and methods; research development workshops and mentorship to develop
successful grant applications for extramural funding; a weekly population studies speaker series
that brings in researchers with outstanding contributions to be shared with Duke and nearby
communities; and a continuous effort to recruit new affiliates from inside Duke with research
resources and to recruit new Duke faculty through cooperation with departments and schools in
these efforts.